ACTIVE SITE STRUCTURES OF ATP UTILIZING ENZYMES

THE SIR SUPPLIED DR. RAO WITH [U-15N]AMP. A NUMBER OF MUSCLE AND METABOLIC DISEASES ARE RELATED TO THE ROLE OF ATP-UTILIZING ENZYMES WHICH ARE IMPORTANT AND UBIQUITOUS IN BIOCHEMICAL PATHWAYS. THE GOAL OF THIS PROJECT IS TO CHARACTERIZE THE ACTIVE-SITE STRUCTURES OF THESE ENZYMES, VIZ. PHOSPHORYL TRANSFER, NUCLEOTIDYL TRANSFER AND PYROPHOSPHORYL TRANSFER, BY USING NMR SPECTROSCOPY. THREE TYPES OF MEASUREMENTS YIELD STRUCTURAL DATA (I) DISTANCES BETWEEN THE CATION AND SELECTED NUCLEI ON THE SUBSTRATES WILL BE DETERMINED THROUGH SPIN-LATTICE RELAXATION MEASUREMENTS OF 31P AND SELECTIVELY LABELED 13C AND 15N NUCLEI OF THE SUBSTRATES IN THEIR ENZYME COMPLEXES IN THE PRESENCE OF ACTIVATING PARAMAGNETIC CATIONS MN(II) AND CO(II) SUBSTITUTED FOR THE NATURAL ACTIVATOR MG(II), (II) ADENOSINE CONFORMATIONS OF ENZYME-BOUND NUCLEOTIDES WILL BE DETERMINED THROUGH TWO-DIMENSIONAL TRANSFERRED NUCLEAR OVERHAUSER EFFECT SPECTROSCOPY (TRNOESY) MEASUREMENTS AND (III) 13C-31P AND 15N - 31P DISTANCES IN 13C AND 15N LABELED NUCLEOTIDES WILL BE DETERMINED IN ENZYME-BOUND COMPLEXES, STABLE IN LYOPHILIZED POWDER FORM, BY ROTATIONAL ECHO DOUBLE RESONANCE (REDOR) MEASUREMENTS. THESE MEASUREMENTS TOGETHER REPRESENT A COMPREHENSIVE STRUCTURAL DATA THAT NMR METHODS CAN PROVIDE ON THE SUBSTRATES BOUND TO THESE ENZYMES. A SPECIAL EFFORT WILL BE MADE TO ASSESS AN ACCEPTABLE RANGE FOR EACH DISTANCE OBTAINED, BY CONSIDERING THE UNCERTAINTIES IN THE NMR DATA, AND IN THE THEORETICAL BASIS FOR THE EVALUATION OF DISTANCES. SIX PHOSPHORYL TRANSFER ENZYMES, THREE AMIONACYL TRNA SYNTHETASES (TWO OF CLASS I AND ONE OF CLASS II) WHICH ARE NUCLEOTIDYL TRANSFER ENZYMES, AND ONE PYROPHOSPHORYL TRANSFER ENZYME (PHOSPHORIBOSYLPYROPHOSPHATE (PRPP) SYNTHETASE) WILL BE INVESTIGATED. ACTIVE-SITE STRUCTURES COMPATIBLE WITH THE STRUCTURAL DATA, ACQUIRE AS ABOVE, FOR THIS DIVERSE GROUP OF IMPORTANT ENZYMES WILL BE CONSTRUCTED BY USING MOLECULAR-GRAPHICS BASED INTERACTIVE COMPUTATIONAL PROCEDURES AND COMPARED.